SCH: Novel and Interpretable Statistical Learning for Brain Images in AD/ADRDs

Biomedical imaging technology has undergone rapid advancements over the last several decades,
producing large volumes of multimodal imaging data that hold great promise as biomarkers for agingrelated diseases such as Alzheimer’s. Current imaging biomarkers are primarily based on specific
extracted one-dimensional measures that may not fully capture the richness of imaging data. Utilizing
three-dimensional (3D) or higher imaging information directly may facilitate the identification of more
effective disease biomarkers to inform diagnosis, prognosis, and treatment. However, this also brings
significant challenges, such as analyzing ir-regularly shaped 3D objects, managing high-dimensional and
high-resolution data, addressing noisiness and complexity, quantifying uncertainty, and ensuring the
interpretability of the results. Our multi-institutional, inter-disciplinary team of investigators will develop
efficient statistical learning approaches and scalable computing tools to extract and assess biomarkers
from large-scale brain imaging studies. We will also incorporate genetic and clinical information in
constructing the biomarkers. Specifically, our proposal comprises five interrelated research aims carried
out by investigators with complementary expertise from three institutions. Aim 1 focuses on developing an
interpretable model for genome-wide association studies (GWAS) with brain imaging pheno-types and
non-visual contextual information. Aim 2 targets to develop novel nonparametric distributed learning
methods for analyzing 3D brain imaging data using an innovative domain decomposition strategy to
improve computing performance. Aim 3 quantifies the bias effect in image processing and develops
inference methods to reveal the underlying signal from brain imaging data and identify significant brain
regions among different diagnosis groups. Aims 4-5 aim to develop statistical methods for obtaining and
evaluating imaging-adjusted biomarkers for disease diagnosis and prognosis and assess the incremental
value of imaging information over genetic biomarkers on diagnosis and prediction accuracy. The efficacy
of the methods developed in this pro-posal will be tested by data collected from studies in Alzheimer’s
disease and brain sciences. The proposed research will address critical gaps in current biomarker
development and analysis by utilizing advanced sta-tistical learning approaches and computing tools to
directly utilize the 3D or higher imaging information. This innovative approach holds the potential to provide
more effective disease biomarkers, leading to improved accuracy in diagnosis, prognosis, and treatment
for Alzheimer’s disease and related dementias.

Public health relevance
By using advanced statistical learning approaches and computing tools to leverage 3D or higher imaging information directly, the proposed research can facilitate the identification of disease biomarkers and improve the accuracy of diagnosis, prognosis, and treatment for Alzheimer’s disease and related dementias. The proposed project has the potential to make an impact on public health by enhancing our understanding of aging-related diseases.